Boston Area Diabetes and Endocrinology Research Center (BADERC)

ABSTRACT
The Boston Area Diabetes Endocrinology Research Center (BADERC) is a consortium of
laboratory-based and clinical investigators whose efforts are directed toward addressing the major
research questions bearing on the etiology, pathogenesis, treatment and cure of type 1 and type
2 diabetes, and their associated microvascular and macrovascular complications. The Center
Director (Jose Florez) and Associate Directors (Barbara Kahn and Alexander Soukas) are highly
productive senior investigators of international stature. The 64 participating scientists, with
combined annual direct costs in excess of $110M in diabetes-related grant support, are based at
various Boston-area research institutions, including the major Harvard Medical School-affiliated
teaching hospitals (the Massachusetts General Hospital, the Beth Israel Deaconess Medical
Center, the Brigham and Women's Hospital, Boston Children’s Hospital) and research institutes
(the School of Public Health, Dana-Farber Cancer Institute, the Broad Institute), the Boston
University Medical Center, and the Tufts New England Medical Center. These investigators are
working at the cutting edge of fields most relevant to defining the pathogenesis and optimal
treatment of type 1 and type 2 diabetes, such as 1) the molecular basis of insulin action and
insulin resistance; 2) the neurobiology of energy balance; 3) the immunologic basis and optimal
therapies for autoimmunity and transplant rejection; 4) the genetic architecture of diabetes and
related traits; and 5) the development of new methods for glycemic monitoring and control. The
BADERC offers these scientists an Enrichment Program and an array of core support services
(Cell Biology, Transgenic Animals, Metabolic Physiology) that incorporate the latest technical
advances in molecular genetics, cell biology, and metabolic physiology provided by
acknowledged experts and provide hands-on training. New Cores in Clinical Investigation and
Bioinformatics are proposed in this application. BADERC investigators also receive facilitated
access to several platforms of the Broad Institute (Genomics, Proteomics, Metabolomics,
Imaging, Gene editing). The BADERC also offers a highly subscribed and successful Pilot &
Feasibility grant program, and BADERC investigators support summer medical students for a
research experience. The easy access to cost-effective support services of outstanding quality,
together with the educational and pilot grants program, have promoted many collaborations, and
attracted new talent from this outstanding scientific community to diabetes research. Finally, the
Center strives to foster the closest interactions between the laboratory based and clinical
scientists, so as to ensure the translation of research discoveries into advances in the care of
patients with diabetes.

Public health relevance
NARRATIVE The Boston Area Diabetes and Endocrinology Research Center (BADERC) provides high quality, cutting-edge and cost-effective technical support to investigators performing research related to diabetes mellitus in the Boston area. It also provides an Enrichment Program and seed grants for diabetes-related research, a resource that has been avidly sought by area investigators. The existence of the Center facilitates multidisciplinary and inter-institutional collaboration as well as multiple training opportunities.